Transplantation of Testis Stem Cells in Large Animals

Project Summary
The long-term goals of this project are to establish germline stem cell (GSC)-based gene editing to
generate large animal models of human diseases and for regenerative medicine (PAR-16-093), and to provide
accessible systems to study the GSC niche in non-rodent animals. The testis stem cell is unique; it is the only
cell type in an adult male that divides and contributes genes to future generations, making it an ideal target for
genetic modification. Pigs are important models for pre-clinical research because they are phylogenetically and
physiologically more similar to humans than rodents. Gene editing through GSCs rather than embryos will
shorten the time necessary to produce germline gene edited animal models. It is also more broadly applicable
to disease models where gene dosage and epigenetics have a role and smaller strains of pigs are required. The
aims of this renewal project are 1) to establish a culture system that promotes porcine germ cell expansion
in vitro; 2) to explore the role of testicular somatic cells in formation of a functional GSC niche; and 3) to
develop a precise approach for targeted gene editing in porcine GSCs. While germline transmission of a
genetic modification is possible with transplantation of primary pGSCs, efficiency of the approach would benefit
from a robust in vitro system for expansion of edited cells prior to transplantation. To accomplish this goal, we
will define the metabolic phenotype of pGSCs to inform design of appropriate culture conditions. Grafting to
mouse hosts and transplantation to recipient pigs will monitor the ability of cultured cells to support
spermatogenesis as functional endpoint. Germ cell function is controlled by interaction with the niche
microenvironment. Our novel testicular organoid system and xenografting of testis cells will enable introduction
of cell type-specific modifications and characterize stem cell-niche interactions. We will test the hypothesis that
primary cilia on testicular somatic cells are essential for niche formation, and that the somatic environment
modulates germ cell differentiation and supports germ lineage differentiation of porcine induced pluripotent stem
cells (piPSCs). Finally, we will test the hypothesis that CRISPR/Cas9 ribonucleoprotein (RNP)-mediated
homology directed repair (HDR) will allow efficient targeted genome editing in GSCs for precise replication of
human disease alleles. As HDR is limited to small DNA alterations (~1-50 bp), we will also explore Precise
Integration into Target Chromosome (PITCh) for targeted gene editing to enable introduction of large transgenes
and/or humanizing parts of the pig genome for regenerative medicine. Introduction of a mutant porcine insulin
gene (INSC94Y) that matches the human INSC96Y mutation present in permanent neonatal diabetes mellitus will
provide proof-of-principle that our novel strategies are feasible and efficient. Overall, this work will establish
precise targeted germline gene editing in pigs, and further define stem cell-niche interactions.

Public health relevance
Project Narrative To study and design treatments for human diseases requires appropriate animal models. Despite the availability of many rodent models, findings in rodents do not readily translate to human patients but large animal models, such as pigs and non-human primates, closely resemble human physiology and size. This project will provide a novel strategy for precise genetic modification in testis stem cells to generate large animal models of human diseases and for regenerative medicine, and will establish accessible systems to study germline stem cell biology in non-rodent animals.